Pre-doctoral Diversity Supplement to TLDK139567

The North Carolina Kidney, Urology, and Hematology Training, Research, Innovation, and Outreach (NC KUH
TRIO) Program (U2CDK133491, TL1DK139567), is an alliance among a trio of prominent academic medical
centers and three Historically Black Colleges and Universities (HBCUs) in the state. TRIO aims to diversify and
advance research in KUH disorders. Led by Principal Investigators—Drs. Ronald Falk for Kidney, Anthony Atala
for Urology, and Thomas Ortel for Hematology—from the University of NC (UNC), Wake Forest University (WF),
and Duke University (Duke), respectively, the program capitalizes on their experience running longstanding
training programs in their disciplines. Their collective experience provides the foundation for this program and
harnesses synergistic capabilities of experienced, multidisciplinary, and enthusiastically collaborative mentors.
Partnerships with the three HBCUs, Winston Salem State University, NC Central University, and NC Agricultural
and Technical State University (A&T), makes use of existing research and mentoring collaborations with the
three larger institutions, bringing the promise of expanding diversity in trainees and mentors. Funding began in
September 2023 and currently supports four pre-doctoral and six post-doctoral positions. Trainees were selected
through a competitive application and review process and are inclusive of all disciplines (K n=7, U n=1, H n=2),
with 3 (30%) trainees from groups identified as underrepresented in science (underrepresented minorities,
disadvantaged, and/or with disabilities). An Administrative Core provides leadership and infrastructure to foster
diverse, integrated activities and address program goals. The Networking Core fosters partnerships with various
programs and NC HBCUs to facilitate a robust pipeline of KUH researchers from high school to early faculty.
Three NIDDK/KUH R25 programs, one each at UNC/NC A&T, WF, and Duke, run by overlapping TRIO faculty,
bring targeted learning to undergraduates in kidney-related topics. HBCU student activities enrich the landscape
of TRIO's training initiatives. These connections feed our pipeline for TRIO trainees and will help expand TRIO
mentors to include more from HBCUs. Early faculty members participate in TRIO activities and near-peer
mentoring with TL1 trainees, and TRIO provides support to help them acquire first-level grant funding. The
Professional Development (PD) Core provides trainees with exposure to multidisciplinary research, technological
innovations, and numerous career advancement skills. Resources are leveraged from three Clinical and
Translational Science Award (CTSA) programs. The Training Core delivers cutting-edge mentored research
training that fosters collaborative, innovative KUH research. TRIO fosters team mentoring and cross-institutional
collaboration among its 69 mentors to maximize trainee support and research impact. TRIO is committed to
expanding support for additional trainees, which includes pursuing Diversity Supplements and other F-level
grants. TRIO is poised for continued growth and impact with the overall goal of empowering a diverse cohort of
future KUH researchers who will ultimately change the lives of patients with KUH diseases.

Public health relevance
Project narrative It is imperative to train researchers in clinical, scientific and technological areas to advance the fields of Kidney, Urology and Hematology (KUH) towards bringing better understanding and management to KUH conditions and diseases. This program in North Carolina combines expertise and novel concepts in Training, Research, Innovation, and Outreach to form the NC KUH TRIO Program, bringing together six institutions across the state; 3 academic medical centers and 3 historically black universities that have strong science, technology, and engineering programs. TRIO will support pre- and post-doctoral trainees, providing them with innovative research tools and a professional development foundation to launch KUH research careers.